Probing the mechanisms and circuits underlying orbitofrontal signaling

Project Summary
Learning the meaning of cues is necessary for survival. Humans and other animals use this information to
learn where and how to acquire food, find mates, or avoid predators. Cues signal many aspects of survival
behavior. For example, road signs tell us which way to turn to acquire food (direction), which specific food is
offered (e.g., ice cream vs frozen yogurt; outcome identity), as well as whether food is offered at all (value).
We are also able to discriminate cues which share the same meaning from their sensory properties (cue
identity - e.g., a red octagon and flashing red light both mean stop). The integrated representation of these
has been called a “cognitive map”.
But how is this kind of information acquired, integrated, and used - what neural circuits underly the formation
and use of cognitive maps? The orbitofrontal cortex (OFC) is thought to play a role in forming cognitive maps.
However, laboratory assessments of OFC and cognitive maps were conducted in situations where cues,
responses, and outcomes were confounded, and not during learning. This leaves open the question of how
and why various forms of information are represented in OFC during learning of a complex cognitive operation.
This proposal will test the hypothesis that formation of integrated representations in OFC depends on activity in
chemosensory, motor, and limbic areas, and OFC ensembles evolve to integrate value-based information.
Rats will perform an odor-guided choice task I developed that de-confounds cues, outcomes, and movement,
and allows me to assess these during learning. Using cell-type specific neural inhibition, I will first test whether
olfactory cortex and limbic areas are necessary for integrating sensory and value information in OFC cognitive
maps (Aim 1). I will then test whether the evolution of cognitive maps in OFC depends on value-based
information (Aim 2). During the independent phase, I will examine the role of taste and motor association
circuits in forming cognitive maps in OFC (Aim 3). I will then record neural activity concurrently in
sensorimotor and medial orbitofrontal cortical networks, allowing me to test whether the acquisition of
sensorimotor correlates varies with information processing in medial OFC (Aim 4).
During the mentored phase, I will receive training critical for my short- and long-term success, including large
ensemble recording, computational analyses of high-dimension data, and cell-type specific circuit interference.
The proposed training program combines hands-on training with expert experimenters, independent study,
formal coursework, and professional scientific meetings. This program will equip me to lead a laboratory
focused on circuits, cell-types, cortical networks, neural representations, and how they contribute to learning
and the generation of complex behaviors.

Public health relevance
Project Narrative Humans and other animals must learn the meanings of cues to survive. Orbitofrontal cortex neurons acquire responses to reward-predictive cues, but it is unknown why and how this information changes during learning, or whether orbitofrontal cortex acts as part of a functional circuit. Results from these experiments will inform our understanding not only of orbitofrontal function, but also of cortical networks and learning, more broadly.